Early Family Member Deaths and Disrupted Transitions into Adulthood

Abstract
Persistent racial/ethnic disparities in mortality in the U.S. create racial/ethnic disparities in young people’s
exposure to death in their families. Such differential exposure to family member deaths in childhood and
adolescence is a significant public and population health issue given the intense disruption of this family
experience, the physical and mental toll of bereavement, and the cascading life course risks of adverse early
life trauma. This project advances a significant interdisciplinary research agenda with an innovative conceptual
model that integrates sociological, biosocial, and psychological perspectives on human development and an
innovative mixed-methods design that combines quantitative analyses of an extant national sample with
quantitative and qualitative analyses of a local lab-based sample. Specifically, building on the PIs’ past
research illuminating the critical role of disrupted young adult transitions in lifelong sequelae of early exposure
to family member deaths, this project will document the links between exposure to family member deaths in the
early life course and unstable and insecure trajectories of socioeconomic attainment and family-building in
young adulthood; elucidate the physiological, cognitive, psychological, and social mechanisms (e.g., emotional
dysregulation, maladaptive learning, physical wear and tear, psychological scarring, counterproductive coping
behaviors) underlying these life course linkages; and identify concrete sources of resilience (e.g., opportunities
to achieve and connect) that allow young people facing such risks to have more stable transitions into
adulthood. These aims will be pursued by applying longitudinal modeling techniques and tools for promoting
causal inference to nationally representative data following adolescents’ transitions into adulthood from the
National Longitudinal Study of Adolescent to Adult Health. That national component will be supplemented by a
local component—its feasibility already validated by a pilot—involving new data from 480 young adults
participating in a laboratory-based cognitive and affective assessments, biosignal tracking, daily diaries,
surveys, and qualitative interviews. Following a sequential mixed methods explanatory design that will result in
a comprehensive visual map of integrated results and insights, analyses of these diverse sources of data will
iteratively inform each other to refine theoretical understanding of the issue and to identify the key mechanisms
that can be targeted for intervention, critical points at which to intervene, and potential social and institutional
supports for resilience leverageable for intervention. Led by senior sociologists with complementary expertise
and track records of NIH-funded translational mixed-methods research, this project will produce protocols,
data, and recommendations that advance theory and facilitate the use of evidence for action around a set of
issues that speak to a contemporary public health crisis. Doing so will galvanize attention to mortality and its
reverberating consequences and to a social justice movement that underscores racial/ethnic inequalities.

Public health relevance
Project Narrative Integrating statistical analyses of nationally representative data with quantitative and qualitative analyses of physiological, cognitive, social, and psychological data from a diverse lab-based sample to document and unpack how racial/ethnic disparities in exposure to family member deaths early in life may destabilize socioeconomic and family-building trajectories into young adulthood, this project will focus attention on a key domain through which this early trauma has lifelong consequences for health, elucidate biopsychosocial mechanisms underlying this life course process that are amenable to intervention, and identify potentially actionable supports for resilience. This theoretically grounded, policy-focused, and pilot-validated research can significantly address an overlooked channel in the intergenerational transmission of racial/ethnic inequality affecting vulnerable Americans, capturing the spirit of Healthy People 2030 and advancing many goals of NIH.